PHASE II, RANDOMIZED, PLACEBO-CONTROLLED TRIAL OF PROSTVAC (PSA-TRICOM) IN PATIENTS... (PROTOCOL UAZ2012-03-01). CONTRACTOR: UNIVERSITY OF ARIZONA. CONTRACT: HHSN261201200031I. PERIOD: 9

The contractor will conduct a phase II randomized, placebo-controlled, double-blind trial of PROSTVAC? in patients with clinically localized prostate cancer undergoing active surveillance to assess the immunological (primary) and clinical (secondary) response to this vaccine.